High-Throughput DNA Sequencer

The Tufts University Core Facility Genomics Core (TUGC) is applying for funds to purchase a high throughput
sequencer, an Illumina NovaSeq 6000. It will be a critical addition to the Genomics Core in support of its
mission to provide high-quality next-generation sequencing (NGS) for the research community within Tufts
University and its affiliates.
The TUGC was established in 2008 to address the budding need for NGS. Due to the tireless efforts of the PI
and his colleagues, it has grown into the only core facility within Tufts University and Tufts Medical Center that
offers a comprehensive NGS service. The core is renowned for its knowledgeable and accommodative staff
that works collaboratively to provide end-to-end NGS services to NIH-funded investigators. In addition to the
standard sample preparation and sequencing services, the TUGC offers its users advice and support from the
initial experimental design through the data analysis and visualization. The core has been supporting high-
impact research covering diverse health- and life-science focused areas including immunology, microbiology &
host-pathogen interaction, cellular & cancer biology, genetic & associated diseases, neurobiology & neurologic
diseases, microbiome, developmental & restorative biology, environmental & populational biology, nutritional
biology, and aging.
The Genomics Core has iterated through several generations of sequencers over the years. Currently, it offers
its NGS services with several Illumina instruments including a HiSeq2500, a NextSeq 550, and two MiSeqs.
Illumina has issued an end-of-life bulletin and will cease its support of the Hiseq instrument in early 2023. The
end-of-life will render it obsolete and result in a severe service gap for projects that require the high data yield
that the HiSeq provides. Thus, there is a dire need for a replacement sequencer to prevent an interruption to
the ongoing research of our NIH-funded investigators. Determining the optimal choice of a HiSeq replacement
requires considering the sequencing needs of ongoing and future research projects, the current array of
instrumentation, TUGC expertise, the future growth of the facility, and new applications. For these reasons,
the Illumina NovaSeq 6000 is the most logical choice. It is the latest model succeeding the HiSeq
1000/2000/3000/4000 series and has become the leading choice for high output instrumentation. It supports
various read lengths of up to 250 bases and offers four choices of flow cells that cater to a range of data yield
requirements. With a 24- to 48-hour output capacity ranging from 65 billion to 6 trillion bases and 650 million
reads to 40 billion reads, it provides the flexibility, scalability, speed, and cost effectiveness required in a multi-
user environment.

Public health relevance
High throughput sequencing, or next generation sequencing (NGS), is a powerful technology for decoding and extracting information from genomes and the Tufts University Core Facility Genomics Core (TUGC) has been providing this crucial technology since 2008. This proposal seeks funds to replace the obsolete next generation sequencer at TUGC in order to preserve and expand its NGS services. These services are critical to a diverse community of life science researchers within and outside of Tufts University.